Protocol Review Monitoring Committee

PROJECT SUMMARY (See instructions): The Protocol Review and Monitoring Committee (PRMC) of the Holden Comprehensive Cancer Center (HCCC) functions to develop and review new cancer protocols and to monitor existing clinical trials. The PRMC performs a rigorous scientific review and monitoring of clinical trial protocols prior to review by the Institutional Review Board (IRB). The PRMC reviews prioritization of clinical studies, increasing accruals to clinical studies, modifications to protocols and closure of studies.

Public health relevance
RELEVANCE (See instructions): The purpose of the PRMC is to ensure adequate accruals to clinical trials, review and monitor existing clinical studies, and ensure scientific purpose of a clinical study.